Comprehensive, high-resolution arrays to trace the development of antibody responses to variant Plasmodium falciparum antigens in naturally exposed cohorts

ABSTRACT:
The global burden of malaria is unacceptably high and would be substantially worse without the development
of naturally acquired immunity, which provides nearly complete protection against disease. Unfortunately,
immunity only develops after years of exposure, in part due to extensive variation in antigens such as P.
falciparum erythrocyte membrane protein 1 (PfEMP1). PfEMP1 antigens allow the parasite to establish chronic
infections and lead to host pathogenesis. Each parasite contains ~60 variable (var) genes encoding unique
PfEMP1 sequences, which are switched during chronic infections. Antibodies to PfEMP1 are important
mediators of immunity, but evaluation of antibody responses to PfEMP1 has been severely limited by an
inability to capture responses to the extraordinary extent of naturally occurring antigenic variation. Furthermore,
most studies have coarsely evaluated responses to large protein domains and are limited by small sample
sizes, precluding the evaluation of longitudinal responses. We are uniquely positioned to address these
limitations, building on our recent advances in bioinformatic and laboratory methods. We recently developed a
method to produce accurate assemblies of var genes from short read sequence data, and a phage
immunoprecipitation sequencing (PhIP-seq) assay that efficiently evaluates antibody responses to the entire P.
falciparum proteome. In this proposal, we will leverage these efforts to develop a high-resolution PhIP-seq
array designed to evaluate antibody responses to the full breadth of PfEMP1 diversity. We will apply this assay
to well-characterized samples from longitudinal studies of malaria in highly endemic areas of Uganda to
evaluate the development of antibody responses to PfEMP1, laying the groundwork for future investigations
including associations of antibodies with var gene expression and clinical immunity. In Aim 1, we will develop
a PhIP-seq array for comprehensive, high-resolution profiling of antibody responses to functional
domains of PfEMP1. We will create a tailored array for PfEMP1 which deeply samples global sequence
diversity and evaluates epitopes at high resolution. To best capture diversity, we will augment existing var gene
assemblies with de novo assembly of sequences from all publicly available P. falciparum whole genome
sequences and additional sequences we are generating. We will evaluate array design approaches using well-
characterized monoclonal antibodies and polyclonal immune sera. In Aim 2, we will evaluate the
development of antibody responses to PfEMP1 in longitudinal cohorts of children and adults naturally
exposed to P. falciparum. We will use PhIP-seq to comprehensively profile antibody responses to functional
domains of PfEMP1 from infancy to adulthood by selecting cross-sectional and longitudinal time points from
existing Ugandan cohort samples. Upon successful completion of this study, we will have developed a low
cost, high throughput method for comprehensively evaluating antibody responses to PfEMP1 and begun to
answer important questions about their acquisition.

Public health relevance
SUMMARY: The most fatal form of malaria is caused by Plasmodium falciparum, a parasite which has evolved a system of antigenic variation responsible for evading the human immune system, establishing chronic infections, and mediating severe and placental malaria. Antibody responses to these variant antigens provide nearly complete protection against symptomatic malaria but are poorly understood since they are difficult to measure. In this proposal, we will develop a new assay to more precisely measure antibody responses to these variant antigens and evaluate acquisition of responses longitudinally in naturally exposed Ugandan cohorts.